Deciphering the mechanism of non-canonical cell cycle entry

Title: Deciphering the mechanism of non-canonical cell cycle entry
PROJECT SUMMARY
The decision to enter the cell cycle is a fundamental cellular process that is critical to development and tissue
maintenance, with dysregulation of this process being responsible for the development of cancer. Initiation of
the cell cycle is regulated by cyclin-dependent kinase 4 and 6 (CDK4/6), which is activated by mitogenic signaling.
Activating mutations are commonly found in mitogenic signaling in cancer cells, leading to overactivation of
CDK4/6 and abnormal cell proliferation. Thus, specific CDK4/6 inhibitors show immense promise as treatments
for various types of cancer. In addition to the canonical CDK4/6-dependent pathway, emerging evidence
suggests that mammalian cells can enter the cell cycle in the absence of CDK4/6 activity. Although the
mechanism by which CDK4/6 regulates cell cycle entry is well established, the molecular mechanisms underlying
non-canonical cell cycle entry remain elusive. The objective of the proposed research program is to determine
the mechanisms of the non-canonical pathway for cell cycle entry. Given cell-to-cell heterogeneity and the highly
interconnected regulatory processes of cell cycle entry, elucidating how and when mammalian cells bypass
CDK4/6 and enter the cell cycle is challenging. To overcome these challenges, we will apply live-cell sensors for
CDK activity in combination with our innovative single-cell methodologies. We will also use a variety of
pharmacological and genetic approaches to manipulate potential regulators of non-canonical cell cycle entry.
Our preliminary data point to a theoretical mechanism for non-canonical cell cycle entry that may at first appear
paradoxical: a tumor suppressor gene that is normally inactivated by CDK4/6 is routed for degradation in
response to sustained CDK4/6 inhibition, thereby providing a means for non-canonical cell cycle entry. Moreover,
our preliminary data implicate multiple factors in the regulation of this process, suggesting a dynamic interplay
of factors that further integrates extrinsic and intrinsic signals to control non-canonical cell cycle entry.
Completion of the proposed research will provide new insight into the dynamic regulation of cell cycle entry and
a greater understanding of adaptations to CDK4/6 inhibition in mammalian cells. In addition, as non-canonical
cell cycle entry severely limits the success of CDK4/6 inhibitor therapy in cancer, outcomes from the proposed
research have the potential to lead to novel therapeutic interventions targeting the cell cycle in cancer.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because dysregulation of cell cycle initiation results in human diseases, such as cancer and degenerative disorders. Outcomes from this research will provide new insights into alternate mechanisms of cell cycle entry that will pinpoint novel targets for therapeutic interventions for cancer and degenerative diseases. Thus, this proposal is relevant to NIGMS’s mission to drive and foster innovative research and strategies to ultimately protect human health.